Function of Phospholipase Cgamma2 in RANKL-Induced Osteoclastogenesis

[unreadable] DESCRIPTION (provided by applicant): The development and homeostasis of the skeletal system depend on the balance between bone formation and resorption. Pathogenic bone resorption modulated by elevation of osteoclasts is a major cause of bone loss in diseases such as osteoporosis, rheumatoid arthritis and osteolytic bone metastasis. Receptor activator of NFκB ligand (RANKL) activates calcium signals that lead to activation of nuclear factor of activated T cells c1 (NFATc1), an essential transcription factor for osteoclastogenesis. Recent discovery of the essential role of costimulatory signals in RANKL-induced osteoclastogenesis provides insights into how RANKL signaling may activate calcium signaling. Costimulatory signals mediated by DNAX-activating protein 12 (DAP12) and Fc receptor common γ subunit (FcRγ) cooperate with RANKL to activate phospholipase C γ (PLCγ), which leads to changes in intracellular calcium. PLCγ has two isoforms, γ1 and γ2. The expression of PLCγ1 is ubiquitous, whereas PLCγ2 is primarily expressed in hematopoietic cell lineages, among which are the osteoclasts. Consistent with a recent study, we found that the global PLCγ2 deficient mice have increased bone mass and decreased osteoclasts. RANKL-induced activation of NFATc1, NF-κB and AP-1 was impaired and in vitro osteoclastogenesis was blocked in the osteoclast precursors derived from PLCγ2-/- mice. Further, we found that retrovirus-mediated expression of PLCγ2, but not PLCγ1, restored RANKL-induced osteoclastogenesis, indicating a unique role of PLCγ2 in osteoclastogenesis. However, it is not clear if PLCγ2 is required to initiate osteoclastogenesis and/or necessary to maintain osteoclast differentiation. The precise role of PLCγ2 in mediating activation of costimulatory signals by RANKL and the necessity of PLCγ2 for costimulatory signals to enhance RANKL-induced osteoclastogenesis have not been well characterized. In addition, the global PLCγ2 deficient mice have many defects in signaling through the immunoglobulin receptor superfamily receptors, including the FcRγ signaling. Thus, osteoclast-specific PLCγ2 deficient mice are proposed to be generated in the present studies, so as to characterize a more definitive role of PLCγ2 in mediating costimulatory signaling in RANKL-stimulated osteoclastogenesis. Base on our preliminary data and published results, we hypothesize that osteoclast-expressed PLCγ2 is required to mediate costimulatory signaling in late stage of RANKL- induced osteoclastogenesis. We will test our hypothesis with three specific aims. Specific aim 1: Define PLCγ2-dependent osteoclastogenesis in vitro; Specific aim 2: Characterize the effects of osteoclast-specific PLCγ2 ablation on bone phenotype; and Specific aim 3: Determine the role of PLCγ2 in RANKL-induced osteoclastogenesis in mice. These studies will define the precise role of PLCγ2 in mediating costimulatory signals in RANKL-stimulated osteoclastogenesis. Elucidating the definitive role of PLCγ2 in osteoclastogenesis and bone homeostasis will expend our knowledge of costimulatory signaling cascade in osteoclastogenesis and may lead to develop novel strategies and targets to prevent and cure osteolytic-based bone diseases. Pathogenic bone resorption modulated by elevation of osteoclasts is a major cause of bone loss related diseases such as osteoporosis, rheumatoid arthritis and osteolytic bone metastasis. This proposal will generate a tissue- specific mouse model to investigate molecular mechanisms of bone destruction by an important enzyme phospholipase Cγ2, which will identify novel targets to design drugs to prevent and treat bone loss diseases. [unreadable] [unreadable] [unreadable] [unreadable] [unreadable]